Loneliness in Aging with Schizophrenia

In recent years there has been increased awareness and concern about the “epidemic of loneliness” among
older adults and other general population, but the prevalence is even higher among people with schizophrenia.
Loneliness is a significant risk factor for medical comorbidity, cognitive dysfunction, reduced functional
capacity, lower well-being, and earlier mortality. The mortality risk associated with loneliness is double that for
obesity, and equivalent to smoking 15 cigarettes per day. Notably, many of the deleterious effects associated
with loneliness parallel those associated with schizophrenia and aging. This convergence raises a question of
whether loneliness significantly contributes to the deficits in health, cognition and functional capacity,
physiologic function, and well-being among middle-aged and older adults with schizophrenia. The proposed
project is the first comprehensive study of the nature, longitudinal stability, and deleterious impact of loneliness
in schizophrenia. Given recent conceptualizations of schizophrenia as a systemic disorder resulting in
accelerated aging, and the manner in which loneliness may evolve over the life-course, the focus for this study
will be on the effects of loneliness with age among middle-aged and older adults with schizophrenia (n=120) as
well as age-comparable non-psychiatric comparison (NC) subjects (n=90). The study employs a longitudinal
burst design, with in-person visits and assessments of key variables at baseline, 6-, and 12-months. For seven
days following each of the three primary study visits, smartphone-based Ecological Momentary Assessment
(EMA) will be used to measure loneliness, social activity, and mood in real-time. Our primary aims include
determining the associations of schizophrenia and aging with persistent loneliness, and the degree to which
the associations are independent of social isolation and depressive symptoms. The other primary aim is to
determine the association of persistent loneliness over 6- and 12-months with levels and patterns of biological
markers of health, medical comorbidity, cognitive dysfunction, functional capacity, and health-related quality of
life. Hypotheses predict schizophrenia being associated with worse and more persistent loneliness, and that
persistent loneliness will be associated with worse biological markers of health and other outcomes. We also
expect these associations to increase with advancing age. Stability and temporal relationships between acute
loneliness, social activity, and mood measured in real-time using EMA, and associations of these patterns with
those from the standard in-person measures will also be assessed. The data from this project will fill a critical
unmet need for empirical data to guide the content and focus of efforts to prevent and reduce deleterious
biological and longer-term health outcomes and diminished well-being in older adults with schizophrenia.
Together, this study represents a significant and innovative step in furthering efforts toward more effective,
comprehensive, individualized prevention and treatment of loneliness and its adverse effects in middle-aged
and older adults with schizophrenia.

Public health relevance
There is a high prevalence of loneliness among people with schizophrenia, yet little is presently known about the effects of loneliness on health and well-being in this at-risk population as they age. This information is critically important as loneliness is not just psychologically distressing, but is also associated with increased risk of worse health outcomes such as medical disorders, cognitive decline, reduced independence skills, worse overall well-being, and early mortality. This study will comprehensively examine the effects of loneliness and aging in schizophrenia in terms of such health outcomes in order to better guide comprehensive personalized care for older adults with schizophrenia.